ASTHMA SCREENING IN WOODLAND HILLS SCHOOL CHILDREN

The objective of this study is to determine the ability of an asthma screening test, using peak expiratory flow rate measurement before and after a one mile run during gym class and a history questionnaire, to identify undiagnosed asthmatic children.